Neoadjuvant Immunotherapy Platform Study Reveals Mechanisms of Response in Hepatocellular Carcinoma (HCC)

PROJECT ABSTRACT
Hepatocellular carcinoma (HCC) is a significant global health problem and is expected to become the third
leading cause of cancer mortality in the United States (US). Among patients with early-stage HCC, approximately
70-80% of patients experience disease recurrence after surgical resection, and no systemic therapy is currently
approved in the perioperative setting. Neoadjuvant immunotherapy (immunotherapy administered prior to a
potentially curative HCC resection) aims to utilize the primary tumor as a source of antigens to enhance systemic
anti-tumor immunity and prevent disease recurrence. Neoadjuvant studies also offer an opportunity to interrogate
the mechanisms behind both tumor sensitivity and resistance to therapies by providing larger quantities of tumor
to enable in-depth profiling of the tumor immune microenvironment (TiME) that is not possible with needle
biopsies. We are conducting a neoadjuvant platform study to evaluate multiple programmed cell death protein-
1 (PD1)-based combinations in HCC. The three study arms are nivolumab (NIVO, anti-PD1), NIVO plus
cabozantinib (CABO, a multi-kinase inhibitor of VEGFR-2, AXL, and c-MET), and NIVO plus relatlimab (RELA,
anti-Lymphocyte Activating 3, LAG3). Our overarching hypothesis is that the addition of CABO and RELA to anti-
PD1 will bypass barriers to recruitment and function of T cells in early-stage HCC. We will also investigate tertiary
lymphoid structures (TLS) as a conserved mechanism of response to neoadjuvant anti-PD1-based
immunotherapy, based on our preliminary data showing a strong association between the formation of TLS and
major pathologic response in HCCs treated with anti-PD1 immunotherapy. In Aim 1, we will utilize high-parameter
multiplex imaging mass cytometry (IMC) on pre-treatment and post-treatment surgical resection specimens to
determine the additive effects of CABO and RELA on the density and spatial relationships of immune cells within
the TiME. We will also evaluate whether the triple combination of CABO, anti-PD1, and anti-LAG3 enhances T
effector (Teff) recruitment, function, and survival in preclinical models of HCC. In Aim 2, we will investigate the
clonal dynamics of TLS that arise within anti-PD1 treated HCCs through T-cell receptor (TCR) and B-cell receptor
(BCR) sequencing of individual lymphoid aggregates. We will determine the immunophenotype of TLS through
spatial and functional analysis of TLS-associated T cells and B cells. In Aim 3, we will determine the cellular
composition and organization of immunotherapy-associated TLS in three-dimensions by employing a new
technology (CODA) that renders 3D reconstruction of 2D image stacks. This aim will provide the first multicellular
structure-function analysis of TLS in immunotherapy-responsive HCC to understand if TLS are highly conserved
within tumors and across tumors. The final deliverable for this project is understanding the mechanisms of
response to promising anti-PD1 combinations, and the identification of effective and feasible therapeutic
combinations in the neoadjuvant setting for HCC that can be brought forward in larger studies to ultimately
improve outcomes for patients with early-stage HCC.

Public health relevance
PROJECT NARRATIVE Most patients who undergo surgery to remove liver cancers experience recurrence of their cancer within a few years. We are conducting a clinical trial of immunotherapy before potentially curative surgery for liver cancer, and are investigating the effect of a brief course of immunotherapy on the removed cancers, to understand if immunotherapy can change the cancers to improve cure rates.